NIGMS Systems & Integrative Biology

DESCRIPTION (provided by applicant): The growing importance of integrative modern biomedical research has created a strong demand for investigators who have the background and training in both the mathematical sciences and biological/medical sciences. The goal of this training program is to recruit and to train students interested in attaining such combined foundations, to educate the next generation of bio mathematical researchers with the skill to solve biomedical issues. Trainees are recruited from pre-doctoral students already admitted to academic departments/units and counseled by participating faculty members. Thirty-five faculty members in over a dozen departments or research units at UCLA participate in this program. The interests of these faculty represent a broad range of biomedical research activities that bridge mathematical modeling and the biological sciences, with special strength in theoretical biophysics, genetics, medical imaging, neurosciences, pharmacology, and physiology with the ability to participate in clinical and translational research activities. The emphasis of the trainng program will be on the early years of trainees' graduate study, providing students an integrated foundation in quantitative methodology, biological training, and research experience in mathematical modeling applications in biology and medicine to serve as a gateway to suitable dissertation research topics and future career paths.

Public health relevance
PUBLIC HEALTH RELEVANCE: The goals of the systems and integrative biology training program at UCLA is to train students to be proficient in both mathematical and biological/medical sciences, in order to help solve sophisticated problems in the increasingly complex world of biomedical research.